Comparing Quality of Care for Pediatric Dental Procedures Conducted in Ambulatory Surgical Centers and Hospital Outpatient Departments

Project Summary
This proposed study seeks to determine if ambulatory surgical centers (ASCs) offer a less costly setting for
delivering high-quality pediatric dental surgical procedures than hospital outpatient departments (HOPDs). For
reasons related to underlying health conditions (e.g., intellectual and developmental disabilities), access to
care, and disease burden, some children require dental surgical procedures under general anesthesia. The
expansion of ASCs may offer opportunities for improving access and reducing the cost of pediatric surgical
dental procedures while maintaining the delivery of high-quality care. Although prior research generally
suggests that procedures conducted in ASCs are less costly and have better or comparable quality to
procedures conducted in HOPDs, these studies have focused on adult and elderly populations and many have
not used rigorous methods for causal inference. Using three data sources, this proposed study will compare
cost (measured by payments by payers and patients, out-of-network bills, and charges) and quality, as
measured by receipt of timely care (measured by time from diagnosis to procedure and distance to care), safe
care (measured by inpatient stays following procedures, emergency department visits, and hospitalizations),
and equitable care (assessed by examining if quality differs by setting of care for historically vulnerable groups,
defined by low socioeconomic status, Medicaid enrollment, minority race/ethnicity, and rurality). Use of three
datasets, namely the universe of procedures paid by Medicaid, a sample of procedures paid by commercial
insurers in all states, and the universe of procedures in Florida, will enable examination of this question in both
publicly and privately insured populations, as well as enable the comparison of cost and quality in ASCs and
HOPDs by payer. Additionally, to address concerns that results may be driven by the fact that studies suggest
that ASCs may treat healthier patients on average, this proposed study will utilize multiple approaches to risk-
adjustment, including using propensity score weighting and exploiting differential access to ASCs across
states.

Public health relevance
Project Narrative This proposed study seeks to determine if ambulatory surgical centers (ASCs) offer a less costly setting for delivering high-quality pediatric dental surgical procedures than hospital outpatient departments (HOPDs). This study will compare the cost and quality of care of pediatric dental surgical procedures delivered in ASCs and HOPDs using three complementary datasets: the universe of procedures paid by Medicaid; a sample of procedures paid by commercial insurers in all states; and the universe of procedures in Florida. Quality will be measured across four dimensions: cost, receipt of timely care, receipt of safe care, and receipt of equitable care.